Repurposing Pyrvinium as an Inhalation Therapy for Idiopathic Pulmonary Fibrosis

SUMMARY
Idiopathic pulmonary fibrosis (IPF) is a fibrosing interstitial lung disease that is characterized by progressive
decline in lung function due to inflammatory and fibrotic changes of the lung parenchyma. The average life
expectancy for patients is only 3-5 years, resulting in the deaths of 40,000 patients each year in the US. There
are only two FDA-approved drugs for IPF that slow disease progression but do not prevent or reverse symptoms
or pathology, and they exhibit significant side effects in many patients. Promising drugs are in development, but
recent clinical trial failures emphasize the need for additional therapeutic approaches. IPF begins following an
insult to the tissue microenvironment, resulting in a loss of alveolar cells, growth of activated fibroblasts
(myofibroblasts), and increased deposition of extracellular matrix proteins, like collagen, leading to scarring,
increased tissue stiffness, and the inability to breathe followed by death. Many cell signaling pathways contribute
to this pathology, including TGFβ signaling. A high content imaging screen was used to discover that the FDA-
approved pinworm drug pyrvinium (pyr) blocks TGFβ-induced fibrosis. Subsequent studies showed pyr
activated casein kinase 1α and downregulated the YAP/TAZ signaling pathway. Pyr appeared efficacious in a
variety of in vitro assays and in vivo studies (intraperitoneal route), but bioavailability problems presented a
challenge for oral administration. Inhalation dosing allows for direct drug delivery to the site of action and may
reduce the possibility of off-target organ toxicity. In preliminary acute toxicity studies, pyr was well-tolerated
when administered as a nebulized aqueous solution to mice, but efficacy was not tested. Therefore, the following
aims are proposed to further develop pyr as an experimental IPF therapeutic designed for inhaled administration.
In Aim 1, pyr will be administered by oropharyngeal aspiration beginning after administration of bleomycin, a
treatment resulting in progressive fibrosis over 3 months. A second animal model will involve administration to
lungs of an adenovirus expressing TGFβ to induce fibrosis. Lungs will be analyzed by histopathological and
biochemical approaches to measure extracellular matrix remodeling, fibrosis, cell proliferation and measures of
toxicity. This study will determine if pyr is safe and effective in two relevant mouse models when administered
via inhalation. Aim 2 will test the ability of pyr to repress fibrosis in ex vivo human precision-cut lung slice tissue
from healthy and IPF patient donors. Assays will include a hydroxyproline assay for collagen, immunoblotting,
and qRT-PCR analysis to measure activity of fibrosis-associated signaling pathways, automated imaging to
quantify alveolar and fibroblast cell density, and histological staining to score changes in cell morphology and
tissue architecture. This study will reveal if pyr can inhibit and reverse fibrosis in a human ex vivo model, adding
relevance to outcomes of the mouse studies, and will be used to test the proposed mechanisms of action for pyr.
These data will also inform the design of IND-enabling safety and pharmacology studies in preparation for a
Phase 1 clinical trial.

Public health relevance
NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a lung disease with a high mortality rate and no truly effective therapeutic options. This project is designed to investigate the safety and efficacy of an FDA-approved drug delivered via inhalation that previously demonstrated suppression of fibrosis in animal models when injected. Successful completion of these studies would support further development, potentially leading to the first effective pharmacotherapy for IPF.